The Experience and Regulation of Posttraumatic Shame among Women with Histories of Interpersonal Trauma

Project Summary/Abstract. Approximately 14 million women in the United States will develop posttraumatic
stress disorder (PTSD) during their lifetime following physical or sexual assault or abuse (interpersonal trauma
[IPT]). Posttraumatic shame – an emotion stemming from harsh attitudes about the self after trauma – is
central to PTSD for many women post-IPT. Yet, knowledge of the frequency, intensity, stability, and triggers of
shame in the daily lives of women with IPT histories is lacking. Further, though shame and guilt (an emotion
defined by negative feelings about one’s actions) are studied separately by researchers, no work has assessed
whether women with IPT histories make similar distinctions and see shame and guilt as differentially
influencing their recovery from IPT. While some work has begun to explore shame-specific emotion regulation
(ER), or processes aimed at changing emotional responses to meet specific goals, it remains unclear which – if
any – ER strategies are effective in reducing the frequency or intensity of shame. Other factors likely to shape
posttraumatic shame regulation – including perceived effectiveness of ER strategies, goals of ER, and PTSD
severity – also have yet to be explored. Addressing these gaps could strengthen treatments for shame and
PTSD. This project will use a sequential mixed methods design to explore 1) daily experiences of
posttraumatic shame (including triggers; frequency, intensity, and stability; relations to PTSD symptoms;
changes over time; and factors distinguishing shame from guilt) and 2) regulation of posttraumatic shame
(including use, perceived effectiveness, and adaptiveness of ER strategies and roles of PTSD symptoms and
ER goals in shame regulation). Both aims will be assessed quantitatively (Study 1) and qualitatively (Study 2).
Study 1 will involve secondary analysis of ecological momentary assessment data on shame and ER obtained
5 times per day for 14 days from 60 women with IPT histories and varying levels of PTSD symptoms. Study 2
will involve qualitative interviews on the experience and regulation of posttraumatic shame with 20-35 women
with IPT histories. It is expected that higher PTSD symptoms will predict higher subsequent shame and that
shame will predict more frequent rumination, emotion suppression, and distraction and less frequent emotion
sharing, emotional reflection, and reappraisal within persons and across days. Relations between shame and
ER strategies are expected to be stronger among women with more severe PTSD symptoms, and reverse
models (ER predicting shame) will be tested. Themes regarding triggers, distinctions between shame and guilt,
consequences of shame, and the role of PTSD symptoms are expected and new themes may emerge. Greater
understanding of the experience and regulation of posttraumatic shame could improve treatments for shame
and PTSD among women with IPT histories and will be key to advancing the PI’s research. This training grant
will facilitate the PI’s progression toward an independent, grant-funded research career examining the role of
emotional vulnerabilities in PTSD among women with IPT histories.

Public health relevance
The proposed project will address critical gaps in current knowledge regarding the experience and management of posttraumatic shame – an emotion consistently implicated in the development, maintenance, and/or worsening of PTSD symptoms among women with a history of sexual or physical assault or abuse (i.e., interpersonal trauma). Existing treatments for PTSD often fail to fully address posttraumatic shame, and untreated shame represents an ongoing risk factor for the development or worsening of PTSD symptoms. Findings from this study hold promise for improving treatment efforts for shame and PTSD by clarifying aspects of how women experience and manage shame after interpersonal trauma.